IGF::OT::IGF : NIH PAIN CONSORTIUM CENTERS OF EXCELLENCE IN PAIN EDUCATION. ADMIN MOD. N01DA-15-4431.POP: SEPTEMBER 18, 2015 - SEPTEMBER 17, 2019.PURPOSE: TO EXERCISE OPTION PERIOD 3 (CONTRACT YE

IGF::OT::IGF : NIH PAIN CONSORTIUM CENTERS OF EXCELLENCE IN PAIN EDUCATION.